Resident Memory T Cells

Project Summary
Resident memory T cells (Trm) are widely distributed throughout the body, remarkably abundant, and protect
against local reinfections and control tumors. Unfortunately, Trm also drive many undesired immune responses
including certain autoimmune, allergic, chronic inflammatory, and graft-versus-host diseases. Gaps in
understanding resident memory T cell development and poor knowledge of how Trm actually function in tissues
is impeding our ability to leverage or manipulate this recently defined cell type for developing new vaccines,
cancer therapies, or treatments for many T cell driven diseases. This proposal will develop new mouse and
human assays to define how Trm function by amplifying signals through local stromal, hematopoietic, and
parenchymal cells. Systemic endocrine consequences of Trm activation will be assessed in vivo. Combinatorial
gene editing approaches will expand our understanding of the molecular regulation of Trm induction. And
application of a newly developed mouse model, allowing exacting manipulation of antigen responsiveness, will
be used to dissect the role of antigen in shaping Trm differentiation during acute and persistent infections or
cancer. Collectively, this proposal will identify new strategies for promoting or engineering Trm development,
with relevance for protecting against infection or cancer, and new strategies for interfering with Trm function, with
relevance for treating inflammatory diseases.

Public health relevance
Project Narrative Resident memory T cells protect against infections and cancer, and also contribute to autoimmunity, allergy, graft rejection, and inflammatory diseases. This proposal will reveal how resident memory T cells are established and maintained and the mechanisms by which they function. Outcomes of this proposal will inform the development of therapies for immune-mediated diseases, vaccines, and adoptive cell therapies for cancer, while also providing new assays and tools for evaluating mouse and human immune responses.